Examining Trauma Prevalence and Exploring Interoception as a Mechanism of Emotion Regulation in MOUD

Project Abstract
The Parent Grant (R01 AT10742; PIs Price & Merrill) is a two-group randomized controlled trial, with repeated
measures, designed to enroll a sample of 330 in medication treatment for opioid use disorder (MOUD) to
assess the effectiveness of Mindful Awareness in Body-oriented Therapy (MABT) as an adjunct to medication
treatment for opioid use disorder (MOUD). The national opioid epidemic requires development of real-world
evidence-based treatments for opioid use disorder, including adjuncts to MOUD. Interventions are needed that
address the complex needs of patients with opioid use disorder, which include substantial mental health co-
morbidity (e.g. PTSD, depression) and high rates of chronic pain. MABT, a novel mindfulness-based
intervention, uniquely addresses aspects of awareness, interoception, and regulation that may be associated
with pain, mental health distress, and behavioral control that increase risk of relapse and poor treatment
outcomes. The proposed Diversity Supplement examines two critical additional research questions. The aims
are: 1) to describe the types of lifetime exposure to trauma and compare types of trauma exposure between
men and women engaged in MOUD, and to examine the relationship between types of trauma exposure and
symptomatic distress in this sample at baseline; and 2) to explore the underlying mechanisms of MABT by
examining interoceptive awareness as a possible mediator of emotion regulation difficulties and other
indicators of mental health distress. It is hypothesized that emotion regulation difficulties in MABT + TAU
compared to TAU only will be mediated by increased interoceptive awareness from baseline to 3-month follow-
up. This application thus addresses key gaps in knowledge that are important for consideration in MOUD
treatment that may be critical for reducing relapse and improving treatment outcomes.

Public health relevance
Project Narrative This study seeks to provide training and mentorship to Dr. Monique Rodriguez to examine research questions specific to: a) the types of lifetime trauma exposure among men and women engaged in medication treatment for opioid use disorder, and the association between types of trauma and symptomatic distress; and b) explore interoceptive awareness as a potential mediator of emotion regulation and mental health indicators. The results from this project will address gaps in knowledge in MOUD treatment research that are critical for consideration in opioid use disorder treatment and relapse prevention, with the goal to improve treatment efficacy and decrease the public health burden of opioid use disorder.